Circuit-Selective Astroglial Plasticity During Opioid Relapse

Abstract
Vulnerability to relapse despite prolonged abstinence is a principal feature of drug addiction. Decades of
research have expanded our understanding of the neural basis of relapse, but have yielded few effective
treatments that restore top-down control over drug seeking in active and former users. In animal models,
repeated drug use, but not repeated exposure to natural rewards, results in excess glutamate transmission within
corticofugal projections to the striatum in the presence of reward-associated cues and contexts that drive
seeking. This behavioral paradigm has been used to model neural adaptations that trigger relapse, since
reactivity to drug-related cues is linked to drug craving in humans. The dysregulation of glutamate transmission
after chronic heroin use arises in part from enduring changes in peripheral astrocyte processes that insulate
active synapses and express the glutamate transporter GLT-1, consistent with a growing literature that illustrates
a prominent role for this cell type in maintaining the integrity of excitatory synaptic transmission. My published
data show that astrocytes in the NAcore undergo profound transient morphological plasticity in response to drug-
but not sucrose-conditioned cues and that this plasticity serves to attenuate seeking behavior. Heroin-associated
cues also stimulate an increase in surface-proximity of GLT-1 on the astroglial membrane, an adaptation
expected to limit glutamate spillover during relapse in preclinical models. The goal of this proposal is to explore
whether measures of astroglial plasticity that I have discovered are linked to transmitter release from cortical
projections within the NAcore and to uncover intracellular signaling events that trigger morphological plasticity in
astrocytes during drug-seeking. A final goal of this proposal is to determine whether cue-induced astrocyte
adaptations impact different post-synaptic targets, since the two principle neuronal subtypes in the NAcore, D1-
and D2-MSNs differentially impact drug seeking behavior. In Aim 1, I will combine confocal microscopy with in
vivo fiber photometry in order to identify the time course of astroglial plasticity during a 2-hr reinstatement
session. In Aim 2, I will pair optogenetics with confocal microscopy to determine whether glutamate from
prelimbic cortical terminals is necessary to drive astrocyte motility and GLT-1 surface diffusion after extinction
from heroin self-administration. In Aim 3, I will interfere with the signaling cascade that drives astrocyte process
motility during seeking using viral-mediated delivery of shRNAs selectively in astrocytes. Finally, in Aim 4 I will
use confocal microscopy in transgenic D1- and D2-Cre rats to determine whether astrocyte processes or surface-
proximal GLT-1 are selectively associated with D1- or D2-MSNs during cue-reinstated seeking. These Aims will
provide me with comprehensive training in optogenetics as well as with viral tools that will allow me to selectively
manipulate protein expression in astrocytes and will link my previous findings with the underlying neural circuitry.
The relevance of this work extends beyond relapse to opioids and may have implications for normal synaptic
physiology underlying motivated behavior.

Public health relevance
Project Narrative Most research to date has focused on transcriptional, epigenetic, electrophysiological and morphological adaptations within neurons to understand drug addiction and relapse. The experiments described in this proposal seek to elucidate important changes occurring in a less well-studied cell type, the astrocyte, and are supported by my recent data that demonstrate a dynamic role for astrocytes within the brain reward circuitry during heroin relapse. The proposed research will address the mechanisms by which astroglial plasticity is triggered by and associates with the local circuitry to attenuate cue-induced heroin seeking and provide me with training in techniques required to more clearly define the role of astrocytes in shaping neural signaling during drug relapse.